Resource Section

PROJECT SUMMARY RESOURCE CORE
The overall goal of the Somatic Cell Genome Editing (SCGE) consortium is to accelerate the development of
translational applications of genome-editing technology, particularly CRISPR/Cas9, taking advantage of recent
successes in gene therapy treatments. The specific goal of the Jackson Laboratory Genome Editing Mouse
Testing Center (JAX-GEMTC) is to develop novel mouse resources to facilitate the validation and optimization
of new genome editing technologies. The RESOURCE CORE of the JAX-GEMTC will support mouse breeding
and colony expansion for genotypic and functional validation of reporters, cohort production, and integration
with the NIH-funded Mouse Mutant Regional Resource Centers (MMRRC’s). The resource will take advantage
of the high-throughput colony management infrastructure of the JAX KOMP2 program and the mouse resource
distribution experience of the JAX Repository. Public availability of these new resources will be facilitated by
the co-localization of the Center with the JAX MMRRC. The Resource goals of this Center will be achieved
through two Specific Aims: 1) Establish production-scale breeding colonies for production of reporter line
cohorts for the JAX-GEMTC. The goal of this Aim is to build production colonies of reporter mice to support all
aspects of the JAX-GEMTC program. Initially, we will import the existing Traffic Light Reporter (TLR) model to
JAX and then the importation additional reporters will follow. Models engineered at JAX as part of the Animal
Model Production section will be screened for germline transmission, and production colonies of all models will
be established for functional validation, baseline testing, and to provide cohorts for the TESTING CORE. 2)
Archive and distribute reporter lines to the scientific community through the JAX-MMRRC. In this aim we will
provide novel reporter lines and all associated information for their use to the MMRRC for distribution to the
scientific community. To accomplish this we will take advantage of JAX’s role as one of the MMRRC centers,
facilitating the submission, archiving, and distribution process.